Research and Methods Core

PROJECT SUMMARY/ABSTRACT (RESEARCH AND METHODS CORE) The objective of the Research and Methods Core of the University of Pennsylvania Telehealth Research Center of Excellence in Cancer Care (Penn TRACE) is to advance the research program of the Center through the design and testing of innovative telehealth strategies to improve effectiveness and access across the cancer care continuum. The Research and Methods Core will develop new methodological approaches using insights from communication science and behavioral economics and employ innovative mixed methods and rapid-cycle approaches to advance the evidence base for optimal telehealth care delivery. The Research and Methods Core will address three major questions: 1) How can we employ insights from communication science and behavioral economics to effectively integrate high-quality telehealth into cancer care delivery?; 2) How can we understand mechanisms of successful telehealth care delivery using multilevel, mixed methods approaches to allow for refinement and more precise application of successful interventions in future projects within and beyond our health care system?; and 3) How can we, through our Center’s research, work to ensure that telehealth reduces, rather than increases, differences in health outcomes and access to digital technologies across all patients? The specific aims of the Research and Methods Core are to: 1) Apply insights and innovations from communication science, behavioral economics, rapid-cycle approaches, and statistical methods to design and test synchronous telehealth strategies, supported by asynchronous elements, to improve the effectiveness and quality of cancer care; 2) Employ advanced mixed methods approaches to elucidate the multilevel individual and contextual mechanisms that contribute to the effectiveness of telehealth strategies; 3) Design, conduct, and evaluate findings from a pragmatic trial and two pilot projects to compare the effectiveness of synchronous telehealth strategies to improve lung cancer care; and 4) Support widespread communication and dissemination of results to clinical partners, community members, and policymakers to advance integration of optimal telehealth care delivery nationally and to evaluate comprehensively the Center’s research progress and success of dissemination and implementation activities. Achieving the Research and Methods Core aims will be central to ensuring that Penn TRACE achieves its goal of producing new fundamental knowledge on telehealth with the potential to transform cancer care delivery, access, and outcomes for millions of Americans.

Public health relevance
The University of Pennsylvania Telehealth Research Center of Excellence in Cancer Care (Penn TRACE) will apply insights from communication science and behavioral economics to design and test synchronous telehealth strategies, supported by asynchronous elements, to improve effectiveness and access across the cancer care continuum, with an emphasis on understanding mechanisms of action. We focus on lung cancer as an exemplary model for telehealth across the care continuum, from screening to treatment to survivorship. Penn TRACE will produce new fundamental knowledge with the potential to transform cancer care delivery and outcomes for millions of Americans.